San Diego StrokeNet+

The San Diego Stroke Net+ RCC is dedicated to managing an efficient RCC, quantifiably increased trial enrollments, robust network collaboration, and enriched career development, all to enhance the stroke trial portfolio and improve care. The results of this application will impact the stroke research field by enabling the discovery of acute, preventative, rehabilitation, recovery, neural regeneration, imaging, and biomarker techniques for stroke. San Diego Stroke Net+ will continue to contribute to Stroke Net and support the NINDS' mission to seek knowledge about the brain and nervous system to reduce neurologic disease burden. Program: UCSD has participated in Stroke Net, SPOTRIAS, NIH, and industry trials in various areas of stroke with leadership and participation in over 70 stroke trials. The network has developed out of a local network, expanded over time and now includes 21 centers spanning three states. UCSD has engaged support from the Vice Chancellor of Health Sciences, CEO, Department Chair, IRB, Contracts & Research Offices, CTRI, ED, EMS, Base Stations, 21 facilities, co-investigators, and team members. Research: San Diego Stroke Net+ has been a leading enroller for the network. The next cycle will focus on enrolling more participants in our 21 RCCs. RCC12 has a strong pool of proven network investigators who have set up their infrastructure and are awaiting to participate in future network trials. We also have the proven capacity to perform trials in pediatrics and rehab. UCSD has submitted trial ideas and is working on additional proposals into the network. We have proven our ability to enroll across the spectrum of care for acute, prevention, recovery, observational, and pediatrics. Leadership: UCSD has designated a PI (Meyer) and substitute PI (Hemmen), each with qualifications to serve. San Diego Stroke Net+ has one member on the Executive Committee, 2 participating on working groups, 2 on advisory committees, and has 3 participants on trial steering committees. Experts from various disciplines collaborate on trials in diverse arenas of stroke management. Trials particularly suited to areas of expertise of research faculty are designated based on area of expertise. Career Enhancement: UCSD has had a commitment to career guidance for trainees for over 35 years. The Stroke Net Career Enhancement Director also serves as the fellow mentor for independent research activities. The training program focuses on research products including scholarly activity and clinical trial ability. Program manager career development also ensures high level research teams are well trained. Administration: UCSD has had great success in producing high quality NIH enrollments due to our standard operating procedures (SOPs). UCSD prioritizes Stroke Net and NIH trials as possible. Allocations grids mitigate against bias. Over many years, San Diego Stroke Net+ has successfully performed trials for the full spectrum of stroke care, and is an ideal choice to continue as a high producing RCC.

Public health relevance
This regional and national research network is relevant to the NIH/ NINDS mission of offering every eligible patient an opportunity to participate in a Stroke Net network trial, to result in improved public health. The short- term benefits of optimizing networks and maximizing efficiencies of stroke clinical trial performance will yield long-term benefits of having more trials across the spectrum of stroke care (prevention, treatment, recovery) completed faster, yielding more treatment opportunities for all. These benefits, coupled with an active career development program, will result in a sustained network with researchers that can further forward a cutting- edge NIH stroke trial portfolio.